Improving Global Measurement of Intimate Partner Violence

PROJECT SUMMARY/ABSTRACT
Significance. Intimate partner violence (IPV), the most common form of violence worldwide, is
associated with a wide range of negative health outcomes for victims and exposed children.
Precise, valid, and transportable measures of IPV are needed to accurately capture the
prevalence of IPV, assess the effectiveness of interventions to prevent and reduce IPV, and
appropriately allocate resources to combat this pervasive global health issue. This project will
address five limitations of current IPV measurement: measurement error, underreporting, lack of
consensus in IPV domains and outcome construction, lack of equivalence across countries, and
small item sets. Aims. This study aims to: (1) assess the performance of a quantitative method to
control for measurement error and underreporting of IPV; (2) identify the best-fitting measurement
model of IPV incorporating physical, sexual, and psychological subdomains in 45 lower- and
middle-income countries (LMICs) and assess its comparability across countries; and (3) test the
appropriateness of the model for higher-income countries (HICs) and assess the item functioning
of IPV scales used in HICs to identify possible items to add to IPV scales currently used in LMICs.
Data. This study will use data from the Demographic and Health Surveys, Multiple Indicator
Cluster Surveys, National Intimate Partner and Sexual Violence Surveys (NISVS), and the
European Union Agency for Fundamental Rights’ Violence Against Women Survey (FRA-VAW).
Methods. For Aim 1, I will apply multiple overimputation to correct measurement error and
underreporting in multipurpose surveys. For Aim 2, I will use confirmatory factor analysis (CFA)
to test the fit of four models of IPV in LMICs and use multi-group CFA to assess their equivalence
across countries. For Aim 3, I will test the fit of the model identified in Aim 2 in HICs and use item
response theory to assess item functioning of scales used in NISVS and FRA-VAW. Impact.
These investigations will inform recommendations to improve the precision, validity, and
transportability of IPV measures, contributing to better surveillance and evaluation of prevention
efforts. Training. This project will strengthen my subject matter knowledge of IPV measurement;
develop key quantitative skills in overimputation, Bayesian modeling, item response theory
methods, and structural equation modeling techniques; and hone my ability to communicate
scientific findings. Formal training, dissemination activities, and the mentorship of Drs. Cari Clark
(sponsor), Regine Haardoerfer (co-sponsor), and Robin Richardson (mentor) will enable the next
steps in my career as an independent researcher in the field of violence prevention.

Public health relevance
PROJECT NARRATIVE Intimate partner violence (IPV), the most common form of violence worldwide, is responsible for a variety of physical and mental health problems for victims and exposed children that can persist throughout the life course. Despite increased awareness of the negative societal impacts of IPV and an international commitment to reducing IPV enshrined in the Sustainable Development Goals, numerous challenges exist in commonly used questionnaires to measure IPV. Improving the precision, validity, and cross-cultural consistency of IPV measurement is a prerequisite for accurately assessing the scope of the problem, evaluating efforts to prevent and reduce IPV, and effectively allocating resources to address this pervasive global health threat.